UNZA-Vanderbilt Training Partnership for HIV-NCD Research (UVP-2)

As access to antiretroviral therapy for HIV has expanded in sub-Saharan Africa, millions of persons with HIV
are surviving for decades on treatment, but they are developing chronic non-communicable disease (NCD)
complications that require new science and new directions in prevention, detection, and treatment. Recogniz-
ing that investigation and control of NCDs can be most effectively undertaken by highly trained local investiga-
tors, the University of Zambia (UNZA)-Vanderbilt Partnership for HIV Nutrition Research Training (UVP-1) has
supported PhD training for 11 Zambian scientists pursuing a wide range of HIV-NCD research and has
helped strengthen the UNZA PhD program and the culture of mentorship at UNZA.
We are now transitioning the UNZA-Vanderbilt Training Partnership for HIV-NCD Research (UVP-2) to
UNZA as the prime institution. Our goals are to build UNZA’s research capacity by continuing our “sand-
wich” model of PhD training and by using a similar model to develop a postdoctoral training program,
with a view to creating a pipeline of independent UNZA scientists. We will also introduce new research
training mechanisms and support structures at UNZA to ensure sustainability. Specifically, we will:
1. Train five (5) UNZA PhD students and four (4) UNZA postdoctoral scientists in advanced basic, clini-
cal/translational, epidemiologic, and implementation sciences to address the complications and comorbidi-
ties most relevant to lifelong HIV management in sub-Saharan Africa
This aim focuses on training individuals. Both training programs will use our very successful “sandwich” for-
mat with Africa- and U.S.-based components. Postdoctoral training is itself innovative for UNZA, and we
will leverage Vanderbilt’s investments in postdoctoral research career development and intensive grant writing
training through the Vanderbilt’s very successful Institute for Research Development and Ethics (VIRDE).
2. Strengthen UNZA’s capacity to train researchers, attract research funding, and generate high-impact
research outputs across a broad range of HIV-NCD investigations
This aim focuses on UNZA’s research training capacity. UVP-2 will support UNZA’s new postdoctoral fel-
lowship mechanism by replicating key Vanderbilt career development resources at UNZA, principally those
associated with successful grant applications, and three-month sabbaticals for four (4) UNZA Visiting Faculty
Scholars at Vanderbilt, focused on developing collaborations and submitting grant applications.
3. Ensure and document UVP’s long-term impact under experienced UNZA leadership
This aim focuses on program impact, which we will evaluate by tracking careers, grants, publications, re-
search teams, and discoveries. The UNZA-Vanderbilt Partnership has proven highly efficient in catalyzing re-
search capacity at UNZA. The addition of the new postdoctoral fellowship and the formation of infrastructure to
increase UNZA’s grant support will usher in a new era of research growth and impact.

Public health relevance
Millions of persons with HIV in sub-Saharan Africa are now surviving for decades on treatment but are devel- oping chronic non-communicable disease complications that require new science and new directions in pre- vention, detection, and treatment. The University of Zambia (UNZA)-Vanderbilt HIV Research Training Partner- ship (UVP) has been extremely successful, achieving all its aims including supporting 11 UNZA PhD students, evaluating and facilitating a new structure for the UNZA PhD Program, and hosting two UNZA Visiting Faculty Scholars at Vanderbilt. We will deepen and extend the impact of UVP in catalyzing UNZA's research capacity by shifting the grant's primary leadership to UNZA, training five UNZA PhD students and four postdoctoral sci- entists, implementating UNZA's new postdoctoral fellowship program, adding two South-South partnerships with the University of the Witwatersrand and the Consortium for Advanced Research Training in Africa (CARTA), and establishing a Biostatistics Support Core service at UNZA.